STAGING PREDIABETES BY BETA CELL FUNCTION FOR PREDICTIVE IMMUNOASSAY

The specific aim of this study is to address the following question: Are basal proinsulin to insulin ratios elevated prior to decine in insulin secretion during IDDM progression?